Project 3 - Novel Therapies for Spliceosomal-Mutant MDS.

Project Summary
Current therapies for myelodysplastic syndromes (MDS) and acute myeloid leukemia (AML) are unsatisfactory.
We and others discovered that components of the pre-mRNA splicing complex are recurrently mutated in
patients with MDS and AML and induce alterations in RNA splicing. Small molecule modulators of this
complex (i.e., splicing modulators) have been developed by our collaborators and others. We recently
reported that expression of mutant splicing factors or pharmacologic perturbation of splicing with splicing
modulators increase the abundance of R loops, which are structures containing DNA:RNA hybrids and
displaced single-strand DNA. R loops trigger an ATR-dependent DNA damage checkpoint response that
mediates resolution of the R loop to protect cells from genomic instability and cell death. Our preliminary
preclinical data suggest that spliceosome mutant cells are more sensitive to ATR inhibition than wild-type cells.
We hypothesize that splicing factor mutations create a vulnerability to ATR inhibition (ATRi) that can be
exploited for the development of novel therapeutic strategies when used alone or in combination with splicing
modulator drugs. We will test this hypothesis in a phase II clinical trial of an ATRi in patients with myeloid
malignancies and using well-defined in vitro and in vivo models. In Specific Aim 1, we will conduct a phase II
trial of ATR inhibition in relapsed/refractory MDS and chronic myelomonocytic leukemia (CMML) and
determine the molecular basis of sensitivity and resistance to this novel therapy. We predict that patients with
spliceosome mutations will have an increased response rate to ATRi compared to patients without a splicing
factor mutation. Correlative studies will assess pharmacodynamic endpoints and examine the mechanisms of
drug sensitivity and resistance, if it occurs. In Specific Aim 2, we will test the efficacy of ATRi in combination
with splicing modulators in models of spliceosome-mutant MDS. Preliminary evidence suggests that exposure
of splicing factor mutant expressing hematopoietic cells to small molecule modulators of the spliceosome
exacerbates R loop formation and increases sensitivity of cells to ATRi. We will use genetically-defined
cellular and mouse models exposed in vitro and in vivo to a variety of spliceosome modulators alone or in
combination with ATRi. Finally, we will perform a genome-wide CRISPR/Cas9 screen to identify genes and
pathways that could sensitize spliceosome-mutant cells to the cytotoxic effects of ATRi that could be pursued
in future clinical trials. This project addresses SPORE translational endpoints by conducting a first in human
clinical trial of an ATRi in patients with myeloid malignancies. We will identify genetic biomarkers that are
predictive of response to ATRi and establish the preclinical data necessary to nominate combination therapies
that could be used to develop the first novel:novel combination of drugs for the treatment of MDS and AML with
splicing factor mutations.

Public health relevance
Project Narrative We and others discovered that RNA splicing, a critical metabolic pathway in cells, is altered in many patients with myelodysplastic syndromes (MDS) and acute myeloid leukemia (AML), leading to the formation of DNA:RNA hybrids in cells (i.e., R loops). Removal of R loops is necessary for cells to survive and is dependent on ATR, a serine-threonine kinase. This project will test the activity of an ATR inhibitor in MDS and leukemia patients in a clinical trial and explore whether adding other drugs to an ATR inhibitor could improve responses.